MURINE MONOCLONAL ANTIBODY 17-1A IN TREATMENT OF PANCREAS ADENOCARCINOMA

The purpose of this study is to determine the response rate, duration of response, safety and improvement of the quality of life following treatment of repeated doses of murine 17-1A to patients with pancreatic carcinoma.